Washington Circle

The purpose of this agreement is to provide support to the Center for Substance Abuse Treatment[unreadable]s (CSAT) initiative with the Washington Circle to advance the science of performance and quality measurement of addiction services.